GH19-015, Malaria Operations Research to Improve Malaria Control and Reduce Morbidity and Mortality in Malawi

RFA-GH-19-015 College of Medicine Malaria Alert Center
PROJECT SUMMARY
Morbidity and mortality from malaria remains unacceptably high in Malawi, despite the scale up
of various malaria control interventions. This high burden could be as a result of problems in 1)
program implementation, 2) uptake and utilization of interventions, 3) absence of a proper
program monitoring and evaluation and possibly 4) lack of relevant research to support the
program. The College of Medicine Malaria Alert Centre is applying to undertake a cooperative
agreement with the Centers for Disease Control and Prevention, USA to support the Malawi
Ministry of Health’s efforts to reduce malaria related morbidity and mortality. This cooperative
agreement proposal has five main objectives. Objective 1 consists of the conduct of malaria
operational research and monitoring and evaluation activities in Malawi. The Ministry of Health
has identified school children as a vulnerable group on top of under-five children and pregnant
women - this is featured highly in this proposal. Objective 2 will develop and validate the impact
of revised, enhanced or novel interventions that will contribute to effective malaria control in
Malawi. Since there is a lot of co-morbidities in Malawi, objective 3 consists of supporting the
Ministry of Health in translating the many operational research findings into policy whilst objective
4 and 5 will improve malaria surveillance systems and build capacity for these in the ministry
respectively.
In order to achieve these, a number of field and laboratory studies have been suggested. A
number of monitoring and evaluation activities have also been proposed, including efforts to build
capacity to evaluate the program. Most of the proposed activities are unique and relevant to the
national and global malaria control agenda. The activities will be conducted in collaboration with
the National Malaria Control Program, with technical support from the Centers for Disease Control
and Prevention (USA) and other centers of excellence. This cooperation will build reasonable
local capacity to undertake future malaria research on behalf of the Ministry of Health. Data and
lessons learnt will be shared with the Ministry of Health, President Malaria Initiative (PMI), USAID
and other malaria implementing partners for wider dissemination, to promote the implementation
of evidence based malaria interventions.

Public health relevance
RFA-GH-19-015 College of Medicine Malaria Alert Center PROJECT NARRATIVE The continued high burden of malaria in face of increased scale up interventions carries with it the obligation for the Malawi National Malaria Control Program and its partners to identify barriers to access to interventions and factors affecting the effectiveness of the program. The goal of this application is to catalyze national efforts to conduct operational research, use evidence based polices in malaria control and mount an effective monitoring and evaluation of the malaria program. These efforts should effectively lead to significant reduction of malaria-related morbidity and mortality in Malawi and in the long term support the elimination of malaria.